Reducing Burden in Care Partners of Community-Dwelling Persons with Dementia and Oropharyngeal Dysphagia

We propose an NIH Stage I (R61) study to adapt, refine, and pilot test a Web-based Care Partner Tool for
Feeding in Dysphagia (WeCareToFeedDysphagia), followed by an NIH Stage IV (R33) full-scale, 24-month,
randomized controlled trial (RCT), to determine the efficacy of WeCareToFeedDysphagia for reducing burden
in care partners of community-dwelling persons with Alzheimer’s disease (AD) and AD-related dementias
(AD/ADRD), diagnosed with oropharyngeal dysphagia (OD) during hospitalization. OD, a devastating
syndrome that affects nearly 90% of hospitalized patients with AD/ADRD, is a significant predictor of care-
partner burden, which, in turn, leads to poor care-partner and patient outcomes (e.g., quality of life, QoL). Our
preliminary data indicate that, upon hospital discharge, care partners of patients with AD/ADRD face dramatic
and persistent unmet OD-related caregiving needs: A. knowledge deficits; B. unrealistic management
expectations; C. patient QoL considerations; D. inability to cope with patient’s frustration/refusal to eat
dysphagia diets; and E. lack of competencies/skills. The overall goal of this proposal is to reduce burden in
care partners of community-dwelling persons with AD/ADRD and OD using a single-component, easily
administered, intervention that addresses unmet OD-related caregiving needs. Guided by a self-regulation
theoretical framework, WeCareToFeedDysphagia will use written and video content, care-partner testimonials,
frequently asked questions, and resource links, to: A. provide accurate information (e.g., dysphagia diets); B.
set realistic expectations; C. identify/support feeding goals (QoL considerations); D. acknowledge/support
care-partner feelings; and E. provide competencies/skills for OD management. The R61 phase will adapt,
refine, and pilot test WeCareToFeedDysphagia to reduce care-partner burden by: adapting our existing web-
based tool by incorporating stakeholder input (Aim 1), resulting in WeCareToFeedDysphagia; refining the tool
through usability/acceptability testing (Aim 2); and conducting a pilot RCT (N=60) to determine the preliminary
efficacy of WeCareToFeedDysphagia to reduce care-partner burden, as well as the feasibility of a subsequent
full-scale RCT (Aim 3). We will assess care partner reported outcomes using technology (e.g., smartphones):
3-month post-hospital care-partner burden (primary outcome) and QoL (secondary outcome). The go/no-go
criteria for the full-scale RCT is defined as: feasibility as ≥50% consented, ≤20% attrition at 3 months, and
≥80% tool engagement; and preliminary efficacy as effect size of ≥0.3 for reducing care-partner burden. The
R33 phase will determine the efficacy of WeCareToFeedDysphagia to reduce care-partner burden by:
conducting a 24-month, full-scale RCT (N=406) at 11 diverse Northwell Health hospitals (Aim 4) and
conducting moderator and mediator analyses to examine the impact on intervention efficacy (Aim 5). The
proposal directly responds to NIA’s strategic direction to develop effective interventions to reduce the burden of
age-related diseases and improve QoL for persons with AD/ADRD and their care partners.

Public health relevance
PROJECT NARRATIVE Oropharyngeal dysphagia (OD), a devastating syndrome that affects nearly 90% of hospitalized patients with Alzheimer’s disease (AD) and AD-related dementias (AD/ADRD), is a significant predictor of care-partner burden. Indeed, upon hospital discharge, care partners of patients with AD/ADRD face dramatic and persistent OD-related unmet caregiving needs, which lead to higher care-partner burden. The Web-based Care Partner Tool for Feeding in Dysphagia (WeCareToFeedDysphagia) addresses OD-related caregiving needs, which will reduce care partner burden and improve outcomes for patients with AD/ADRD and their care partners.